Pediatric Persistent Post-surgical Pain: From Animals to Application (Supplement)

Project Summary/Abstract Pediatric chronic pain is a serious public health problem resulting in high levels of healthcare utilization and disability. The physical and psychological consequences associated with chronic pain impact overall health and can predispose the development of adult chronic pain. Specifically, there has been an inadequate amount of research conducted on pediatric chronic postsurgical pain (CPSP), which is urgently required given that over 5 million children undergo surgery each year and 25% of adults presenting to chronic pain clinics identify surgery as the antecedent. The current translational research project utilizes animal models, humans, genetics, and psychophysiological techniques to enhance our understanding of these mechanisms. The long- term goal of this K23 award is for the candidate to establish an independent translational research career aimed at developing mechanistically based behavioral interventions. The intent of the proposed project is to develop an animal model exploring how gene-environmental interactions, age, and biological sex contribute to pre- and post-surgical pain thresholds, which will serve as a first step to functionally assaying genetic mechanisms we hope to discover in the gene association arm of our human studies. The human arm of this project is two-fold; examining the role of childhood stress and genetic pain risk on current pain and functioning in a large cohort of adult surgical patients, as well examining the sensory, psychosocial, and genetic predictors of CPSP and related functional disability in adolescent patients with idiopathic scoliosis (AIS) undergoing spinal fusion surgery. This population was selected as a model condition as patients with AIS are usually otherwise healthy, the surgery is invasive and complex and the candidate’s research indicates that that a high proportion of these patients go onto to develop moderate to severe pain 5 years after surgery once the patients are adults. The primary training objective of the K23 has been to acquire expertise in pain genetics, animal models, and translational research. The candidate is accomplishing this through: 1) mentorship in a clinical/research environment, 2) hands-on training in animal models and genetics by the candidate’s sponsor and co-sponsors complemented by didactics in genetics and advanced statistics, and 3) execution of the proposed research plan. These studies will provide the necessary data to inform the development of an R01 to focus on an epigenetic model to identify study genes, which markedly alter the risk profile for CPSP and which will inform the development of new drug targets and behavioral interventions for those at greatest risk.

Public health relevance
Narrative Public Health Relevance: Persistent moderate to severe pain following major pediatric surgery impacts nearly 20% of patients 5 years post-surgery. Understanding the genetic underpinnings of persistent pain and how genetic background interacts with psychological and environmental factors can inform future treatments to ameliorate patients’ suffering, making it a critical area of empirical investigation.